The TMEM16 Family of Ion Channels and Lipid Scramblases

Project Summary/Abstract
To initiate molecular characterization of the CaCC calcium-activated chloride channels that have been found
in multiple neuronal types since 1980s, we first showed that CaCC is formed by TMEM16A or TMEM16B in
2008. The mammalian TMEM16 family with ten members turns out to be surprisingly diverse, with family
members acting as calcium-activated ion channels and/or calcium-activated lipid scramblase. The TMEM16
family members provide a variety of activities in central neurons to serve important functions such as
modulation of neuronal excitability and thermoregulation. Indeed, some of the mammalian TMEM16 family
members have been associated with human diseases such as febrile seizure and neurodegeneration as well
as Scott syndrome, a bleeding disorder. Therefore, it will be important to conduct molecular and cell biological
investigations to learn about the mechanisms that underlie the functions of these TMEM16 family members.
To ask how the calcium-activated chloride channel works, we solved cryo-EM structures of calcium-free and
calcium-bound TMEM16A and carried out structure-inspired site-directed mutagenesis to identify 10 pore-
lining residues important for anion selectivity and 7 pore-lining residues near pore constrictions important for
channel gating. We then showed that TMEM16B modulates action potential waveform and firing patterns in
multiple brain regions. To ask how TMEM16F fulfils the dual functions of calcium-activated ion channel and
calcium-activated lipid scramblase, we examined cryo-EM structures of TMEM16F and conducted structure-
inspired site-directed mutagenesis to provide evidence for separate pathways in TMEM16F for ion permeation
and lipid scrambling.
To establish the physiological importance of TMEM16 family members, we generated knockout (KO) mice to
show that they provide mouse models for human diseases, such as the bleeding disorder Scott syndrome
(TMEM16F), febrile seizure (TMEM16C), and the progressive neurodegenerative disease spinocerebellar
ataxia (TMEM16K). To monitor endogenous TMEM16C in various cell types in the brain, we modified the split
GFP approach by using CRISPR mediated knock-in to fuse the FLAG tag along with the 11th beta strand of
GFP to the C-terminus of TMEM16C, and expressing GFP1-10 (the rest of GFP) in a Cre-dependent manner
in specific cell types. This approach will allow visualization of fluorescently tagged endogenous proteins as
well as identification of their associated proteins for better understanding of their physiological functions.

Public health relevance
Project Narrative Having shown that calcium-activated chloride channels (CaCCs), which serve important physiological functions including modulation of neuronal signaling, are encoded by TMEM16A and TMEM16B of the TMEM16 family of “transmembrane proteins of unknown function,” we were surprised to find that TMEM16C assembles with the Slack sodium-activated potassium channel in dorsal root ganglion nociceptive neurons to modulate neuronal excitability and pain sensitivity, and TMEM16C function in the brain is important for homeostatic thermoregulation. It was also surprising to find that TMEM16F not only has the dual functions of calcium-activated cation channel and calcium-activated lipid scramblase but is also required for extracellular vesicle formation. This project aims to investigate the molecular and cell biological mechanisms underlying important functions of these TMEM16 family members in neuronal signaling, thermoregulation, and neurodegeneration.